Designing selective TALK-1 inhibitors to reduce beta-cell dysfunction in diabetes

Insulin levels are inadequate to maintain euglycemia in patients with type-2 diabetes mellitus (T2DM) and in animal models of the disease, which is due in part to perturbations in β-cell Ca2+ homeostasis. TALK-1 chan- nels are key regulators of pancreatic β-cell electrical excitability, Ca2+ handling and glucose-stimulated insulin secretion (GSIS). KCNK16 the gene that codes for TALK-1 is the most abundant K+ channel transcript of the β-cell and TALK-1 is the most islet-restricted ion channel. Moreover, a mutation in KCNK16 results in neonatal diabetes and a nonsynonymous polymorphism in KCNK16 causes a predisposition for developing T2DM. However, our ability to utilize TALK-1 as a therapeutic target to normalize β-cell Ca2+ homeostasis in T2DM has not been determined. The long term goal of this research is to determine the therapeutic potential of targeting TALK-1 for treating diabetes. The objective of this project is to identify how TALK-1 influence β-cell Ca2+ han- dling, insulin secretion and glucose homeostasis. This project will test the central hypothesis that TALK-1 inhi- bition normalizes β-cell Ca2+ homeostasis under diabetic conditions preventing β-cell dysfunction and maintain- ing euglycemia. This project is supported by strong preliminary data that has identified TALK-1 an important determinant of human and rodent β-cell ER Ca2+ handling and insulin secretion. Further data that has opti- mized a thallium (Tl+) based fluorescent assay for a high throughput screen (HTS) of human TALK-1 to identify small-molecule probes of this channel; pitot screens (3248 small molecules) also identified the first pharmacol- gocial probes of TALK-1 activity. The rationale that underlies this project is that understanding how β-cell func- tion is influenced by TALK-1 channel activity with genetic and small-molecule probes will expose novel thera- peutic targets for treating T2DM. This project will be accomplished with the following two specific aims: 1) De- velop potent and selective small-molecule probes of TALK-1 channels; and 2) Determine the therapeutic po- tential of targeting β-cell TALK-1 channels for treating diabetes. Under the first aim, small-molecule probes of TALK-1 will be identified with a Tl+ assay based HTS of human TALK-1. This aim will utilize iterative parallel synthesis and verification approaches, to optimize TALK-1 small-molecule probes; testing selectivity (with TALK-1 knockout mouse β-cells), potency, toxicity and drug metabolism pharmacokinetic (DMPK) profiles with assays such as Tl+ flux, Ca2+ flux, cytotoxicity and tier one in vitro DMPK. Under the second aim, conditionally ablating, blocking or pharmacologically modulating TALK-1 channels in mouse and human β-cells will be uti- lized to determine how these channels influence ER Ca2+ stores, cytoplasmic Ca2+ homeostasis, membrane potential, GSIS, and glucose homeostasis. The roles of β-cell TALK-1 will be assessed under physiological conditions as well as under the stressful conditions associated with diabetes both in vivo and in vitro. This pro- ject is significant because it is expected to lead to pharmacological strategies for treating diabetes; it is essen- tial for uncovering novel β-cell selective therapies for normalizing ER Ca2+ homeostasis in diabetic conditions.

Public health relevance
Project Narrative: The discovery of how TALK-1 channels control -cell function under physiological and diabetic conditions will determine the therapeutic applicability of targeting this islet-restricted ion channel for treating diabetes; thus, the proposed research will provide fundamental knowledge about diabetes that is relevant to public health. Results from this project are also expected to provide significant insights about using small-molecule probes of TALK-1 channels as therapies for treating diabetes. Thus, the proposed research is relevant to NIH’s mission that pertains to developing fundamental knowledge that will help reduce the burdens of human illness.